Integrated Biological Systems Training in Oncology

The Integrated Biological Systems Training in Oncology (IBSTO) program was established in 2008, with the objective of providing pre-doctoral students and post-doctoral fellows with cancer-focused training that integrates basic biological processes and translational research through understanding of the approaches and model systems that fuel cancer discovery. The IBSTO philosophy is that future breakthroughs in the diagnosis, prevention, and treatment of cancer will most likely be made by those individuals who are facile in a broad suite of methodologies and approaches, who understand the importance of collaboration and cross-disciplinary research, and who can bridge the divide between basic scientific discovery and clinical implementation. The IBSTO program takes place in a vibrant and inclusive cancer-forward research environment with superb resources, state-of-the-art facilities, top-ranked basic science departments, an outstanding NCI-designated comprehensive cancer center, and world-class basic and translational researchers and physician-scientists. Since its inception, we have recruited an outstanding cohort of more than 60 pre- and post-doctoral trainees, researching in the laboratories of well-funded and productive preceptors in a wide range of areas including cell biology, genetics, biochemistry, structural biology, cancer immunology, computational and systems biology, single cell approaches, omics, and translational cancer research. Productivity and outcomes for IBSTO trainees—both short and long term—are superb. In this third renewal application, we fortify our traditional areas of training strength and introduce a number of exciting and innovative new initiatives that keep this program fresh and effective. Four pre- and four post-doctoral trainees will spend two years each in the program, receiving a foundational training in cancer biology, sharing their discoveries, being exposed to the latest in basic and translational cancer research, and receiving intensive training in grant writing, scientific and communication, and career building. A new career series "Cancer Research Journeys" will provide first-hand exposure to the interplay between scientific discovery and professional development in the cancer realm. A new signature course "Scientific Exposition and Ethics in Cancer Research" will coach skill building through the lens of communication and interactivity, and teach the tools, approaches, and strategies needed for an impactful career that contributes to the amelioration of cancer. A streamlined administrative structure will keep the program nimble. And a new program co-Director will further our efforts, bring new ideas and energy, and position IBSTO for continued success in the next period and beyond.

Public health relevance
The Integrated Biological Systems Training in Oncology (IBSTO) program, begun in 2008, prepares pre-doctoral students and post-doctoral fellows for careers in cancer research by comprehensive training in basic and translational oncology, communications, and career building. The IBSTO program takes place in a world-class cancer research environment with state-of–the-art facilities, experienced preceptors, extensive resources, and strong institutional support. The long-term mission of the IBSTO program is to advance excellence in cancer research and to enable and empower talented trainees to pursue impactful career paths that contribute to the amelioration of cancer.